The role of notochord derived signaling, mechanical force generation and AF derived Tgfβ signaling on intervertebral disc formation

PROJECT SUMMARY / ABSTRACT
Intervertebral disc (IVD) injury such as herniation and degeneration can result in low back pain which is a
leading cause of global disability. Tissue engineering strategies which successfully recapitulate IVD structure
could restore function and reduce the burden of IVD injury. However, intervertebral disc development is not
well understood, hindering the therapeutic targeting of key molecular factors. Initially, the IVD center, the
nucleus pulposus, arises from the segmentation of the continuous notochord through the movement of
notochordal cells out of the future vertebra body and into the intervertebral disc. The IVD fibrous exterior, the
annulus fibrosus, arises from sclerotomal cells which surround the notochord and differentiatiate through the
deposition of aligned collagen fibers production of extracellular matrix. Molecularly, the notochord is a source
of the secreted morphogen Sonic Hedghehog (Shh), and annulus fibrosus expresses the growth factor Tgfβ.
This grant will test the necessity of the notochord in two different stages of IVD development: proliferation, and
actin fiber formation in the AF. The second aim will determine the role of the mechanical force generation,
myosin, actin filament formation and Rho pathway activation on AF formation. The last aim determines the
quantitiative expression and necessity of Tgfβ signaling in AF differentiation including cell alignment and
extracellular matrix deposition. This project utilizes mouse genetics to manipulate molecular cues, and assays
the molecular and phenotypic effects with in situ hybridization, immunohistochemistry and RNA sequencing.
The successful completion of the project will provide insights on molecular and mechanical drivers of
intervertebral disc formation and yield insights which can be used for developing repairs for painful IVD injury.

Public health relevance
PROJECT NARRATIVE During intervertebral disc development, proteins direct differentiation processes that result in the mature organized structure which allows the intervertebral disc to function. This project is to understand the necessity of proteins during specific steps of intervertebral disc formation i.e. the alignment of perpendicular fibers of the outer disc, and the geometric changes of tissue primordia. The essential proteins for intervertebral disc development could be therapeutic targets for intervertebral disc repair which could reduce global disability.